Administrative Core

Abstract – Administrative Core
The Administrative Core of the Scalable TELeheaLth cancer cARe (STELLAR) Center on Telehealth Research will provide the overall organizational and administrative oversight and management of Center activities. This will include developing and applying a cohesive operational framework as well as overseeing the fiscal management, evaluation, communication, and dissemination activities of the Center (including the Research and Methods Core, Rapid Cycle Pilot Studies, Clinical Practice Network, and Pragmatic Trial). The Administrative Core will facilitate STELLAR communications within and beyond the Center (e.g., via a website, e-newsletter, and annual retreats). It will create and employ policies and procedures for the organizational structure, leadership, ethical conduct, and clinical trials oversight of all Center activities. The Administrative Core will develop and implement methods and processes for monitoring the fiscal, scientific, and dissemination progress, timelines and milestones of all Center components and activities. It will establish and convene an External Advisory Board, Internal Advisory Board, Community Advisory Board, and Policy Advisory Group of key stakeholders who will help guide the Center’s work by identifying strategies that optimize telehealth delivery, maximize the external validity of research findings, and support dissemination of project findings and resources. The Administrative Core will be comprised of five components created to direct work integral to Center goals, the: Steering Committee; Operations Team, Evaluation Center, Accessibility Working Group, and Dissemination and Education Committee. The latter will lead efforts to promote opportunities for trainees and early-stage investigators to participate across Center components and activities. The Administrative Core’s aims are to (1): provide management, coordination and evaluation of STELLAR components and activities within a cohesive organizational infrastructure; (2) facilitate and oversee communication and engagement across the Center in order to enhance the research capacity of the proposed studies and sustainability of clinical tools and programs; and (3) accelerate dissemination of project processes, tools, and findings (locally and nationally) in order to advance a robust evidence base for fully integrated, telehealth-based comprehensive cancer care. Efforts will emphasize synergistic collaborations of transdisciplinary teams toward STELLAR’s overarching goal to optimize comprehensive and accessible cancer care by leveraging telehealth delivery and emphasizing cancer risk behavior treatment services.